Transgenic and Knockout Core

Cell Biology Program - The mission of the Cell Biology Program is to: 1) Define the molecular and cellular basis of neoplastic transformation, growth, and metastasis; 2) Provide insights into normal and aberrant functions of genetic lesions; and 3) Provide a foundation of outstanding molecular cell biology to support and synergize with the Center's organ-based cancer programs. Many of the translational interactions with the clinical programs (and even other basic science programs) and with projects in the various SPOREs have emanated from this program. During the past five years, cancer funding has continued to grow. As can be seen on review of Section 8.1, there have been many high-impact, cancer-focused publications from this program.